Deciphering LKB1-associated immunotherapy resistance in lung adenocarcinoma (LUAD)

SUMMARY
Lung cancer is the leading cancer killer in the United States. Our team proposes to develop novel personalized
therapeutic strategies by exploiting vulnerabilities and opportunities created by alterations in tumor suppressors
in lung cancer. Specifically, we focus on the tumor suppressor LKB1, which is one of the most commonly mutated
genes in lung adenocarcinoma (LUAD); LKB1 mutations are detected in 15-25% of LUAD, representing a major
subpopulation of lung cancer patients. Despite the frequency, upward trajectory of incidence, and aggressive
nature of disease, patients with LKB1-mutant LUAD not only have no targeted therapeutics available, but also
show poor response to immune checkpoint inhibitors, demanding urgent development of effective therapeutic
options. To address this critical gap, our revised application will capitalize on our integrated understanding of
LKB1-loss–evoked tumor growth regulatory mechanisms and suppression of anticancer immunity to develop
innovative clinical approaches for the treatment of patients with LKB1-mutant LUAD. New preliminary data from
our team showed that 1) LKB1 loss allows metabolic dysregulation, such as glutamate dehydrogenase (GDH)
activation by FAK, leading to increased regulatory T cells and immune suppression; 2) LKB1-loss-triggered
inhibition of STING, a key innate immunity regulator, can be reversed by an IAP inhibitor, leading to reactivated
immune response and its potent in vivo immune-dependent anticancer effect; and 3) FAK is activated in LKB1-
deficient cancer cells and supports cell invasion and inhibits immune infiltration. These results lead to our central
hypothesis that mutated LKB1 may exert its immune suppression function through a dysregulated anti-cancer
immunity cycle mediated by key metabolic, innate immunity, and stromal regulatory factors. Targeting these
factors may lead to novel approaches to re-activate anticancer immunity for effective therapeutic development
in LUAD. We will address this hypothesis through three highly integrated Projects. Project 1 will examine the role
of the FAK-GDH1 axis in immunotherapy resistance and tumor progression of LKB1-mutant LUAD. Project 2
will exploit our recently discovered LKB1-regulated IAP-JAK-STING signaling in LUAD to reverse immune
suppression with an IAP inhibitor to enhance immunotherapy effect. Project 3 will focus on targeting FAK-
mediated primary tumor progression in LKB1-mutant LUAD by performing a clinical trial with the combination of
a FAK inhibitor and an immune checkpoint inhibitor coupled with mechanistic studies. The projects are supported
by three cores, whose functions are administrative (Core 1), molecular pathology and immunology (Core 2), and
bioinformatics and biostatistics (Core 3). This highly integrated effort builds on new discoveries from our
established lung cancer team with more than 100 co-publications and with strong institutional support. We expect
to advance lung cancer treatment strategies by new agent discovery (GDH1 inhibitors), new application of clinical
stage IAP inhibitors, and a new phase II clinical trial of a FAK-targeted combination approach to overcome
immunotherapy resistance of LKB1-mutant LUAD and bring treatment options to this patient population.

Public health relevance
NARRATIVE Lung cancer accounts for more than 1.5 million deaths worldwide each year. This proposed Emory University P01 program intends to generate new therapeutic strategies for treating lung cancer patients by improving understanding of the dysregulated growth regulatory and immunotherapy resistance mechanisms in lung cancer patients with lost LKB1. Overseen by an Executive Committee, Internal and External Advisory Boards, the program will encompass three interconnected research projects supported by three core resources and an interdisciplinary team that will integrate novel insights from LKB1 biology and its role in resistance to immunotherapy in order to discover innovative clinical strategies for lung cancer patients based on LKB1 status.